Defining target specificity of oxadiazole 2-oxides in Ancylostoma ceylanicum

DESCRIPTION (provided by applicant): Abstract PI: VERMEIRE, JON J. Project: 1K22AI089969-01 Title: Defining target specificity of oxadiazole 2-oxides in Ancylostoma ceylanicum Accession Number: 3233568 ================== NOTICE: THIS ABSTRACT WAS EXTRACTED FROM APPLICATION AND HAS NOT BEEN PROOFED BY AN SRA.WHEN THERE ARE PROBLEMS WITH THE APPLICATION SCANNING PROCESS, THE EXTRACTED TEXT MAY BE INCORRECT OR INCOMPLETE. ================== J. Vermeire - Project Summary/Abstract Hookworms remain a major health burden in the developing world, with hundreds of millions currently afflicted by these bloodfeeding parasites. Future efforts to substantially reduce hookworm disease will likely require the joining of conventional control methods with alternative strategies such as vaccines and novel therapeutics. Development of such strategies requires identification of targets essential for parasite survival. In this regard hookworm enzymes involved in bloodmeal metabolism are attractive drug and vaccine targets. In addition to providing essential nutrients, bloodfeeding also exposes hookworms to potentially toxic iron-containing compounds, which mediate the generation of free radicals and oxidative products. Thus, it is highly likely that the adult hookworm, which feeds aggressively on host blood, has evolved an efficient mechanism for detoxifying the reactive oxygen species that are generated through hemolysis of red blood cells and protease mediated digestion of hemoglobin. Antioxidant systems of bloodfeeding, intestinal nematodes represent an extremely important yet understudied area of helminth biology. Therefore, one important aspect of the proposal includes characterization of hookworm antioxidant pathways in order to better understand their role in parasite biology and host pathogenesis. The other focus of the research outlined in the proposal is to define the target(s) of oxadiazole 2-oxides in the human hookworm Ancylostoma ceylanicum. Preliminary data reveal that these nitric oxide-donating compounds are highly toxic to the adult stages of A. ceylanicum. Recent work has identified oxadiazoles as lead compounds targeting the trematode multifunctional redox protein, thioredoxin glutathione reductase (TGR), and suggest their efficacy as new drugs for helminths. Hookworms do not express this gene product, instead relying on separate enzymes for thioredoxin and glutathione reductase activities. Therefore, the mechanism by which oxadiazoles kill hookworms remains unknown. The proposed experiments are designed to 1) systematically identify and characterize the thiol redox pathways in A. ceylanicum, 2) define target specificity and inhibitory action of oxadiazole compounds on A. ceylanicum redox pathway members, and 3) abrogate adult A. ceylanicum redox activities in vivo using neutralizing antibodies and oxadiazole compounds. The experimental design includes methodologies that will allow the PI to develop technical skill in areas critical to future success. The proposal specifically outlines how K22 support will augment and build upon the PI's previous research experience and postdoctoral training by providing essential opportunities for scientific development and professional growth. Funding of this K22 award will maximize the potential of the PI to establish himself as an independent investigator in order to make a meaningful contribution to the field of molecular helminthology. J. Vermeire -

Public health relevance
Project Narrative The experiments delineated in this proposal are designed to characterize hookworm antioxidant pathways and the effect of a new class of lead drug compounds on their activity. This is directly relevant to public health because it will provide information about the role of these enzymes in parasite biology and host disease. Information gained from these experiments may directly contribute to the development of new drugs for the treatment of human hookworm disease. The experiments delineated in this proposal are designed to characterize hookworm antioxidant pathways and the effect of a new class of lead drug compounds on their activity. This is directly relevant to public health because it will provide information about the role of these enzymes in parasite biology and host disease. Information gained from these experiments may directly contribute to the development of new drugs for the treatment of human hookworm disease. __SpecificAimsTextDelimiter__ A. Specific Aims Hookworm infection remains a major health burden in developing nations, with nearly one billion persons infected. Hookworms are able to survive for years within the hostile environment of their hosts. Although effective anthelminthic agents for hookworm have been available for years, chemotherapeutic interventions have thus far failed to significantly improve the health of people living in highly endemic areas. There is no currently available hookworm vaccine, and with the recent emergence of drug resistance in human isolates, the benefit of mass treatment campaigns might only be short-lived. In light of this, successful control of hookworm infection and disease may require strategies that combine efforts to improve sanitation with novel chemotherapeutics and/or vaccines. At present, little is known regarding the strategies employed by hookworms to evade host immune responses and persist, and this represents a critically important gap in our knowledge of hookworm biology. Adult hookworms secrete numerous factors at the site of attachment in the intestine, including anticoagulants, protease inhibitors, and orthologues of human cytokines. Similarly, the mechanisms utilized by hookworms to deal with the oxidative insult produced through the degradation of hemoglobin in the bloodmeal and by host immune responses remain speculative. I hypothesize that the Ancylostoma ceylanicum antioxidant enzymes of the thioredoxin (Trx) and glutathione (GSH) pathways play a central role in hookworm pathogenesis by detoxifying reactive oxygen species (ROS) produced during bloodmeal metabolism and from the oxidative burst of the host immune response. This defensive action likely promotes parasite survival during host tissue invasion and at the site of attachment to the small intestine. Preliminary data reveal that A. ceylanicum express genes that comprise complete, yet distinct, Trx and GSH pathways. These gene products, present in native extracts of adult worms, excretory/secretory (ES) proteins and as recombinant proteins, are enzymatically active and effective at reducing hydroperoxides in vitro. Furthermore, oxadiazole 2-oxides, compounds recently determined to target the redox protein thioredoxin glutathione reductase (TGR), are effective at killing A. ceylanicum adult worms ex vivo. Moreover, a single oral dose of the oxadiazole compound furoxan is associated with reduced severity of anemia and worm burden following challenge infection, providing evidence that targeting of hookworm thiol redox systems represents a viable strategy to reduce sequelae of disease. Taken together, these data suggest that hookworms have evolved complementary antioxidant pathways with potentially crucial roles in parasite survival and host pathogenesis. Preliminary data gathered thus far have led to the development of these hypotheses: Hypothesis 1: A. ceylanicum possess fully functional and distinct Trx and GSH thiol redox pathways. Hypothesis 2: Oxadiazole 2-oxide compounds target A. ceylanicum Trx and GSH pathway members, disrupting essential parasite redox activity. Hypothesis 3: Neutralization of Trx and GSH pathway gene products in vivo will impair hookworm development and bloodfeeding, thereby limiting hookworm-induced pathogenesis. In order to test these hypotheses, the following specific aims have been developed: Specific Aim 1: Identify and characterize the thiol redox activities of Trx and GSH pathways in A. ceylanicum Specific Aim 2: Define target specificity and inhibitory action of oxadiazole compounds on A. ceylanicum Trx and GSH redox activities Specific Aim 3: Abrogate adult A. ceylanicum redox activities in vivo using neutralizing antibodies and oxadiazole 2-oxide compounds These studies are significant in that they will provide insight into hookworm antioxidant pathways that coordinate to provide an adaptive response to host immune responses and the highly toxic by-products of bloodmeal metabolism. The approach employs contemporary molecular and biochemical assays and a reliable animal model of hookworm infection to characterize nematode biology. These studies utilize innovative hookworm culture methods and will establish a novel paradigm through which reliable tools for gene discovery and characterization will be coupled with powerful new technologies and applied to the study of an important human parasite. The scope and cohesiveness of the proposal's aims are such that they will provide a solid foundation for the principal investigator to successfully transition to independence, fulfilling the purpose of the K22 funding mechanism. Finally, the PI is well qualified to carry out these studies that may ultimately lead to development of novel strategies for reducing the devastating impact of hookworm infection on global health. Figure 1. Ancylostoma hookworm attached to the intestinal mucosa